Clinical Products Center

The Clinical Products Distribution Center contract provides support for the Immune Tolerance Network, which conducts clinical trials and performs clinical research studies. The contract also provides support for other investigator-initiated clinical trials.